Innovation through Interactions

PROJECT SUMMARY/ABSTRACT
Natural products have provided the key starting materials to improve human health by providing therapeutic
agents and structural templates for medicinal chemists for generations. Thus, the field is certain to remain
contemporary if it continues to embrace the current challenges of human health. The American Society of
Pharmacognosy (ASP) as well as this conference focuses on discovering molecules from nature and advancing
their application to improve human health. The theme for the 2023 meeting in Bethesda, MD is “Innovation
through Interactions” and will highlight the various rich interactions – between scientific collaborators, synergism
among natural products, interactions between symbionts and pathogens – that has led to and will lead to
important discoveries that impact human health.
The aim for this proposal is to identify diverse speakers and content for the 2023 ASP conference, including
equal representation of women, and representation from underrepresented groups and diverse institutions. Our
goal is to reduce registration rates to encourage attendance by undergraduate and graduate students as well as
faculty from our regional minority serving PUIs and HBCUs. Support for this project will further facilitate outreach
activities to increase the diversity of the attendees. A second key aim for this meeting is an assessment of
panomics approaches to the discovery and development of natural product prototypes for the treatment of
emerging infectious diseases and using immunomodulation for disease control. The need for better controls for
emerging infectious diseases needs no explanation; however, the role of natural products as critical starting
materials and new prototypes will be addressed as part of the 2023 ASP conference. The final key aim is to
stimulate interdisciplinary collaborations to solve next generation challenges. The ASP meeting will provide the
venue and interactions to catalyze collaborations and networking, which will spur creative interdisciplinary
discussions and drive new ideas for solutions. We fully anticipate that natural products will serve the needs of
human health by providing new prototypes and biological properties well into the future. This conference will
showcase many aspects of these emerging needs with cutting-edge approaches that are moving the field forward
at an accelerated pace. We have and will continue to select leaders in the field to serve as conference chairs
and speakers that align well with the mission of the NCCIH, including a significant number of speakers with
expertise in analytical techniques for evaluating and standardizing materials used as complementary medicines.
This project seeks funding to support the ASP meeting that will be held July 22-26th in Bethesda, MD. The ASP
is the largest society in the USA that focuses on natural products. Support from the NIH will help offset
registration fees and assist with travel for students and new faculty from the US and US Territories with a strong
focus on regional HBCUs of the mid-Atlantic, US. Thus, this meeting will assist to train the next generation of
scientists through the recruitment and support attendees from the PUIs with a focus on the mid-Atlantic, US.

Public health relevance
PROJECT NARRATIVE Natural products have historically played a critical role in providing new prototypes for the treatment of many diseases, including cancer, infectious diseases, and neurological disorders, and the need for new small molecules, for emerging pathogens, could not be more evident from the impact of SARS-COV2-19 and antibacterial resistance on global health. The 2023 American Society of Pharmacognosy conference will provide an outstanding venue for education, training, and stimulation of new collaborations in the areas of drug discovery and development, the roles of natural products in nature, and the broader impacts of natural products on human health. This project aims to support registration and partial travel fees for underrepresented groups in science, including regional HBCUs.